Nur77: Novel Mechanistic Insights and Activation in COPD

Chronic obstructive pulmonary disease (COPD), usually caused by cigarette smoking, is rising in prevalence
and is predicted to become the leading cause of death worldwide by mid-century. Available treatments provide
only short-term benefit, and fail to stop COPD’s inexorable progression. Even smoking cessation, after the
earliest stages, provides limited benefit. New mechanistic therapies to halt progression are thus urgently
needed. COPD pathophysiology includes bronchial inflammation and remodeling, combined with septal
destruction/emphysema driven by inflammation-associated oxidative stress and protease secretion.
Inflammation-driven apoptosis of airway epithelial cells (AECs) is also thought to contribute to airway
remodeling. Based on promising preliminary findings, the proposed research will test the novel hypothesis that
agonist activation of the orphan nuclear hormone receptor Nur77 may have beneficial effects in COPD.
Preliminary findings revealed that AECs and lungs of COPD patients and also lungs of mice with cigarette
smoke (CS)-induced COPD exhibit marked downregulation of Nur77 expression. We also found that Nur77
knockout (KO) exacerbates CS-induced inflammation and lung damage in mice, suggesting a protective role of
endogenous Nur77. We tested the effects of treatment with the classical Nur77 agonist cytosporone B and
found it ameliorated CS-induced lung damage and inflammation in mice, leading us to hypothesize that Nur77
agonists may be useful in COPD therapy. Our in silico findings show that Nur77 exhibits dual (classical and
alternate) ligand binding sites. No alternate site ligand had been identified, but to assess any potential
beneficial effects of activating it we used in silico modeling to identify a novel compound that in vitro studies
demonstrated binds to the Nur77 alternate site, and found that it is an agonist that activates Nur77
transcriptional activity more effectively than cytosporone B. CS extract in vitro causes AECs and type ll
pulmonary ECs to become apoptotic, a pathway that potentially contributes to COPD. Nur77 localization to
mitochondria is known to trigger apoptosis, leading us to hypothesize that CS extract is inducing movement of
Nur77 from the nucleus to cytoplasm and thence to the mitochondria. Our preliminary data show that our novel
alternate site Nur77 agonist reverses such COPD-associated cytoplasmic localization by anchoring Nur77 to
its target response elements in the nucleus, thus ameliorating inflammation and apoptosis of lung ECs. Based
on these novel findings, the aims are to: 1: Determine whether endogenous suppression of nuclear and total
Nur77 activity that occurs in COPD promotes disease progression and severity. 2: Test if activating Nur77
ameliorates COPD severity and progression and its contributing lung EC apoptosis. We will achieve these
aims by treating human AECs of healthy controls and COPD patients in vitro with our novel, effective Nur77
agonist, and testing its effects in mice ± transgenic global or AEC-specific Nur77 deletion, in a standard CS-
induced murine COPD model. The results will elucidate a protective role in COPD of the receptor Nur77, and
may identify it as a promising new therapeutic target for specific agonists to treat a widespread fatal disease.

Public health relevance
Available treatments for chronic obstructive pulmonary disease (COPD), a very common and progressive fatal disease that afflicts many among the high proportion of VA patients who are smokers, provide no more than short-term benefits, if any. Nur77 is an orphan receptor in cell nuclei, whose incompletely known functions include anti-inflammatory actions and the ability to induce cell death by apoptosis in certain circumstances. The receptor is unusual in that it can be activated by ligand binding to either of two distinct sites. Based on our novel identification of the first known ligand for Nur77’s binding site 2 and finding that it stimulates Nur77’s anti- inflammatory activity more effectively than classic site 1 ligands while uniquely blocking Nur77-involved apoptosis, this project will determine the role of Nur77 in COPD and test the mechanisms and potential therapeutic value of novel Nur77 activation site 2 activators. Our anticipated finding will thus point toward a new avenue of effective COPD therapy.